EFFECT OF ORAL CLONIDINE ON GASTRIC EMPTYING IN DIABETIC PATIENTS

The purpose of this research is to determine of oral clonidine will improve the time it takes for gastric emptying in patients with diabetic gastroparesis.